RNA-mediated endotheliopathy in diabetic vasculopathy

Project Summary
More than 10% of the global adult population currently lives with diabetes mellitus (DM) and are
experiencing or at higher risk for various diabetic vasculopathies such as peripheral artery disease (PAD).
Despite available treatment, many patients with DM continue to develop diabetic vasculopathy, highlighting the
urgent need for more effective therapies. Mounting research has shown that the dysfunction of endothelial cells
(ECs), known as endotheliopathy, plays a crucial role in the onset of DM and its vasculopathies. However, there
is still a gap in knowledge regarding the epigenetic regulators that drive endotheliopathy in DM and cause
persistent vascular damage, and whether these regulators can be targeted for treatment.
Synergizing efforts from our funded studies on long non-coding RNA (lncRNA)-regulated EC function
(R01HL145170) and diabetic epigenetic memory (R01HL106089), my group has uncovered important roles of
non-coding RNAs, including microRNAs and lncRNAs, in endotheliopathy, vascular inflammation, and impaired
vascular regeneration in DM and diabetic PAD. Furthermore, we identified chromatin-associated lncRNAs as
key mediators of metabolic memory, which may explain the persistent vascular damage observed in patients
with DM, even after restoration of normoglycemia. We have also broken new ground to unravel the role of the
N6-methyladenosine (m6A)-modified epitranscriptome in DM-induced endotheliopathy and to harness
nanoparticles and modified RNA to develop therapeutics that target the dysfunctional EC epigenome.
In this R35 application, our overall vision is that elucidating the RNA-mediated epigenetic and
epitranscriptional mechanisms underlying DM-associated endotheliopathy in depth will enable us to develop
novel therapeutics to ameliorate diabetic vasculopathy. Our proposed studies will bring together expertise in
RNA, chromatin, and endothelial biology; gene therapy; and nanomedicine to address this pressing medical
issue. We will achieve our goals through three independent yet inter-connected projects to: 1) identify the roles
and mechanisms of action of novel lncRNA regulators in driving endotheliopathy and diabetic vasculopathy; 2)
determine the role of m6A RNA modification in diabetic endotheliopathy and vasculopathy; and 3) evaluate the
efficacy of innovative nanoparticle-mediated epigenetic therapeutics in ameliorating diabetic vasculopathy, with
a focus on PAD, a painful disease with limited treatment options. The unique R35 Emerging Investigator Award
mechanism will allow me to further my group’s research on RNA-mediated endotheliopathy by testing new
hypotheses using innovative technologies. Aligned with the NHLBI mission, our proposed studies will advance
our understanding of diabetic vasculopathy and have the potential to facilitate the development of much-needed
new therapies for patients with diabetic vasculopathy.

Public health relevance
PROJECT NARRATIVE Diabetes is a metabolic disease that can also lead to extremely serious vascular (i.e., blood vessel) disease. This project will provide novel insights as to why patients with diabetes are susceptible to developing vascular disease and will fill important gaps in our understanding of mechanisms that connect metabolic dysregulation with impaired vascular function. We will also develop novel nanomedicine to target these mechanisms for treating diabetes-associated peripheral artery disease, which has very limited therapeutic options.